Effects of binge alcohol drinking on synaptic computing in the nucleus accumbens

This admistrative supplement research grant is seeking funding to train Timmy Le, a UMass Medical
School graduate student eligible under the NOT-OD-20-031 Underrepresented Categories B and
C. The ambition of this administrative supplement grant proposal is to identify the cellular
underpinnings of the early transition between casual to sustain drinking using drinking-in-the-dark
model. Over the course of this project, Timmy le will learn to use and implement a variety of
complementary approaches, including mouse genetics, optogenetics, behavior and biophysical
approaches to test the overarching hypothesis that computing of the synaptic strength of cortical
and amygdala inputs (a phenomenon also known as synaptic gating) is a mechanism enabling
nucleus accumbens medium spiny neurons to integrate cognitive and emotional information, and
is modulated by alcohol exposure to control consumption. In addition to acquiring new technical
skills, he will also receive intense training in conceptual aspects of drugs of abuse and in oral and
written presentation skills.

Public health relevance
Alcohol addiction is a neurological disease that affects millions of individuals in the U.S. and worldwide for which the efficacy of current pharmacological treatments remains limited. To improve such treatments, a better understanding of the long-lasting changes in neuronal communication that occur following chronic alcohol exposure is critical. It has been theorized that the transition from casual to compulsive drinking is driven by poor decision-making, a phenomenon particularly strong during adolescence and whose influence diminishes with age. The initial loss of control over alcohol consumption may be caused by the weakening of the frontocortical-reflective system, and by the concomitant strengthening of the amygdala-impulsive system. The objective of this project is to test the existence of a cellular correlate of this theory in the nucleus accumbens (NAc) by examining how nucleus accumbens medium spiny neurons compute competing cognitive and emotional information coming from the prefrontal and amygdala regions, respectively, and how binge alcohol drinking controls this phenomenon. To explore this question, we will combine in vitro patch-clamp recordings, 2-photon laser scanning microscopy, and a novel double-optogenetics technique in naive and alcohol treated wild-type and transgenic mice.